Extracellular Matrix Regulation of Inflammatory Signaling in Tendon

Abstract
Twenty percent of all primary care consults are related to musculoskeletal diseases; 30% of these are
associated with tendinopathies. Pathogenesis of tendinopathy includes increased inflammatory signaling and
extracellular matrix (ECM) remodeling. This remodeling leads to softer tendinopathic tendons, increasing the
risk of tearing. Yet the relative roles of chronic inflammation and ECM stiffness in the initiation and progression
of tendon disease remain controversial and are difficult to decouple in patient populations. We and others have
shown that, in 2D cell culture using interleukin-1β (IL-1β) as a stimulant, patient-derived tendinopathic
fibroblasts exhibit a stronger inflammatory response that is further enhanced on soft substrates. This
inflammatory response is dependent on NF-κB signaling, which we have previously established as a critical
regulator of tendon disease and healing. Yet these studies are limited by the use of classical 2D culture
approaches and fail to recapitulate in vivo cell behavior or provide insight into ECM remodeling. The ability to
visualize cytokine receptor clustering in 3D environments has further demonstrated that cellular sensitivity to
cytokines is based on the properties of the ECM. Although these studies suggest physicochemical coupling
between ECM stiffness (physical) and inflammatory signaling (chemical) that sustains chronic loss of tendon
mechanical function, the mechanisms of how ECM drives cell behavior in 3D tissues like tendon remain
unknown. Therefore, there remains a critical need to define the physicochemical cell-ECM interactions that
regulate tendon function to discover the mechanisms underlying tendinopathies and treatments. Our long-term
goal is to develop therapeutic strategies for the clinical treatment of tendinopathy by identifying key cell-ECM
mechanisms driving chronic inflammatory tendon disease. Our overall objective in this application is to develop
a novel approach to studying the physicochemical coupling between ECM stiffness and inflammatory signaling
by developing a tendon specific microphysiological system (MPS) with tunable stiffness. In Aim 1 we will
establish a tendon specific MPS with tunable ECM stiffness that quantifies mechanical function in situ. We will
quantify tendon function by measuring micro-cantilever displacement in situ and tune ECM stiffness using light-
induced matrix polymerization. In Aim 2 we will demonstrate that inflammatory signaling in primary human
tendon fibroblasts is modulated by ECM stiffness via inflammatory receptor clustering. In Aim 3 we will
evaluate if and how pathogenic tendon fibroblast phenotype is regulated by ECM stiffness. At the completion of
this proposed work, our expected outcomes are to develop an MPS relevant to tendon function and deliver
new insight into tendon cell-ECM interactions that govern tendon pathogenesis. These results will have a
positive impact by providing the field with a repeatable and tunable platform to improve our understanding of
tendon pathology, ultimately leading to new opportunities for the development of novel therapies.

Public health relevance
Project Narrative This application aims to engineer a novel tendon specific microphysiological system to understand how loss of extracellular matrix stiffness increases inflammatory signaling in tendinopathy. Knowledge gained from these studies will inform development of therapeutic targets to treat tendon disease.